Mechanisms of Asymmetric RNA segregation in C. elegans Development

DESCRIPTION (provided by applicant): The three aims of this project address the function of molecular asymmetries that occur very early in animal development, and the mechanisms by which they arise. Asymmetric cell division is essential for generation of cell-type diversity during differentiation and development. Failure o properly undergo asymmetric cell divisions can lead to defects in stem-cell renewal, tissue regeneration, and can contribute to carcinogenesis. We propose to use a near-ideal natural system, the early C. elegans embryo, to characterize the mechanisms of asymmetric distribution of cellular contents in specific blastomeres with modern genomic tools and analysis, followed by tests of function. Specifically, this proposal aims (1) to use blastomere-specific isolation, RNA- seq, and other high-throughput sequencing applications to comprehensively map RNA inheritance and transcriptional activity of seven invariant cell divisions in early C. elegans development, (2) to test the biological significance of asymmetric RNA segregation in development, and (3) to define the cis and trans-acting mechanisms required for asymmetric RNA segregation. To achieve these goals, we will also apply new approaches and technologies to the study of asymmetric segregation of cellular components. Our research plan is likely to identify cell-fate determinants and mechanisms that are generalizable to other systems, including humans.

Public health relevance
PUBLIC HEALTH RELEVANCE: One of the earliest events in human development is the creation of asymmetry, or making one cell different from another. Generating asymmetry is important for the creation of different cell types during development, for example heart cells versus liver cells. This grant explores the molecular mechanisms that are behind the asymmetric distribution of cellular contents in the very earliest embryonic divisions and selected adult cell divisions. What we discover may help us understand human development, possibly leading to an increased understanding of birth defects and disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Asymmetric cell division unevenly distributes cell fate determinants and is a key mechanism in the generation of metazoan cellular diversity. Failure to properly partition cell fate determinants results in defects in development, stem-cell renewal, tissue regeneration, and can contribute to carcinogenesis. Genome-wide analysis of asymmetric cell division has been stymied by the difficulty in isolating daughter cells in large enough quantity for high-throughput techniques. This proposal aims (1) to comprehensively map RNA inheritance and transcriptional activity in specific, invariant, asymmetric cell divisions in early C. elegans development, using blastomere-specific isolation, RNA-seq, and other high-throughput sequencing applications, (2) to test the biological significance of asymmetric RNA segregation in development, and (3) to define the cis and trans-acting mechanisms required for asymmetric RNA segregation. We will also apply new approaches to the study of asymmetric RNA segregation to identify generalizable biological mechanisms. Aim 1. Identify the asymmetrically segregated RNAs in each cell division of the early embryo We will characterize asymmetric RNA apportionment in the first 7 cell divisions in C. elegans development. A. We will hand-isolate specific C. elegans blastomeres prior to the onset of zygotic transcription from asymmetric divisions at the 2-cell stage (AB vs. P1) and at the 4-cell stage (P2 vs. EMS) and characterize RNA transcripts in each cell. We have developed an extremely sensitive RNA-seq protocol and applied it to hand-isolated AB and P1 blastomeres. Preliminary data show that we can identify asymmetrically segregated transcripts and validate them by independent experimental methods. B. We will expand this strategy to include divisions that occur after the onset of zygotic transcription: the decedents of AB (6 cells total), plus E, MS, C, and P3 (10 cells total). The 15 cells to be analyzed in Aims 1A and B offer a comprehensive assessment of the RNA apportionment in early embryogenesis, comprising every cell along the path to an entire organism. C. To validate the transcripts identified in 1A and 1B, we will apply new technologies to the study of asymmetry. This includes developing a toolkit for visualizing RNA transcripts by Single-Molecule Fluorescence In Situ Hybridization (SM-FISH) and RNA stem-loop tags recognized by modified RFP or GFP proteins (see also Aim 3). In the longer term, we will develop blastomere-specific versions of total RNA-seq, small RNA-seq, and GRO-seq to explore how non-coding RNAs, miRNAs, and de novo transcription contribute to asymmetric cell division and early embryogenesis. Aim 2. Test the functional significance of asymmetric RNA segregation in development A. We hypothesize that asymmetric transcript accumulation functions to produce lineage-specific cellular characteristics. With a tiered approach, we will use RNAi to screen for developmental defects in the top 50 transcripts identified as differentially enriched in each cell from Aim 1. Leveraging existing RNAi phenotype databases, we will perform fine-scale phenotypic analysis of lineage defects by high- resolution video microscopy. This strategy has already identified an intriguing phenotype from a transcript enriched in the anterior AB cell, F32D1.6, which we provisionally name nof-1 (no front end). B. A major question is whether proteins encoded by asymmetrically abundant RNAs will be correlated, anti-correlated, or uncorrelated to RNA levels. We will utilize existing antibodies and GFP fusion proteins encoded by asymmetric RNAs to test the significance of RNA asymmetry on protein production. Aim 3. Identify the cis-acting RNA elements and the trans-acting factors required for asymmetric RNA segregation A. To identify the cis-acting RNA elements required for asymmetric RNA segregation we will search for RNA sequence motifs, structural motifs, and evolutionarily conserved regions that may direct transcript asymmetry. We will also search for motifs in the promoters of asymmetrically segregated transcripts that may direct modifications required for asymmetric segregation. We will test 6 transcripts that are required for cell-lineage specification for functional tests. The tests will include directed UTR mutagenesis and a swap of selected UTRs to see if we can misdirect RNAs. Phenotypic analysis in mutant backgrounds will test whether asymmetry itself is required for biological function. B. To identify trans-acting cellular mechanisms required for asymmetric RNA segregation, we will use the SM-FISH and RNA stem-loop tags of selected asymmetric RNAs to test whether known RNA pathways (exosome, RNAi machinery, de-capping, RNA decay or poly-adenylation) are required for the skewed distributions identified in Aim 1. This will allow us to assign asymmetric RNAs to the pathways upon which they depend. For RNA-binding proteins found to be required, we will perform PAR-CLIP to determine the full suite of RNAs that are bound by the protein, and to better resolve the exact RNA sequences required for the interaction.